IGG SUBCLASS DEFICIENCIES &SELECTIVE ANTIBODY DEFICIENCIES IN CHILDREN

A double blind randomized placebo controlled trial to determine if intravenous immunoglobulin infusions reduce the frequency or severity of recurrent sinopulmonary disease in patients with IgG subclass deficiencies and/or selective antibody deficiencies.